FabI Inhibitors as Potent, Gut Microbiome-Sparing Antibiotics

PROJECT SUMMARY/ABSTRACT
The percent of Gram-negative bacterial infections that are resistant to common antibiotics has increased at an
alarming rate over the last decade, and there is now an acute need for the discovery of novel antibiotics
effective against multidrug-resistant Gram-negative pathogens. We have made progress understanding the
relationship between physicochemical traits and compound accumulation in Gram-negative bacteria, enabling
us to convert several antibiotics with Gram-positive-only activity into versions that possess activity against key
Gram-negative pathogens. Most advanced is our FabI inhibitor fabimycin; FabI inhibition is a novel strategy
with no approved antibiotics that hit this target. The nature of the FabI enzyme is that it is only essential in
certain pathogenic bacteria, chief among them E. coli, K. pneumoniae, and A. baumannii; thus while fabimycin
is effective against large clinical isolate panels of these pathogens, it has no activity against beneficial
commensal bacteria that reside in the gut. A Gram-negative active antibiotic that spared the gut microbiome is
without precedent and would be a very significant development, given the well-documented deleterious effects
of broad-spectrum antibiotics in causing gut dysbiosis. In addition, our X-ray structures of fabimycin bound to
FabI reveal critical interactions between the ligand and the protein backbone, making bacterial resistance much
more challenging to arise than if interactions were solely with amino acid sidechains. Indeed, fabimycin has a
low frequency of resistance, and resistance in cell culture only evolves over a long period of time. Excitingly,
fabimycin is also active in multiple mouse and rat infection models, including those of soft tissue infection,
pneumonia, sepsis, and UTI. To become a true clinical candidate the Therapeutic Index (TI) of fabimycin needs
to be widened. Herein we propose development of more potent versions of fabimycin through application of a
recent understanding of the relationship between compound efflux and structure that has emerged from our
laboratories. Applying these lessons to fabimycin will enable us to systematically reduce its efflux liability,
leading to MIC values for optimized derivatives that are 5-fold more potent than fabimycin and will thus have
the appropriate TI for advancement. We have assembled a team of experts with the full suite of tools needed
for this work: medicinal chemistry, understanding of efflux, access to large panels of clinical isolates,
sophisticated models of antibacterial efficacy in mice and rats, and detailed pharmacokinetics and toxicology
in mice, rats, and dogs, and microbiome studies in mice and dogs. Our Critical Path provides specific criteria
for compound advancement and we are guided by best practices for antibiotic drug development as deliniated
by the FDA. Our plan is to select the lead candidate by the end of Year 2, and then spend the remaining three
years building a sophisticated data package that will facilitate rapid translation of this antibiotic to the clinic.

Public health relevance
PROJECT NARRATIVE It has been over 50 years since the FDA approved a new class of drugs to treat infections caused by Gram-negative pathogens such as E. coli, K. pneumoniae, and A. baumannii, and as such there are now limited options for these infections. We have identified a very promising antibiotic candidate, called fabimycin, that has single-agent efficacy against these drug-resistant Gram-negative pathogens, is from a novel drug class, acts through a novel mechanism (inhibition of FabI), has a low frequency of resistance, has efficacy in challenging rodent infection models, and has no effect on commensal bacteria, suggesting the possibility that it could spare the gut microbiome. Herein we propose a comprehensive and systematic plan to develop novel versions of fabimycin where the Therapeutic Index is widened such that the lead can advance as a true translational candidate; such an antibiotic with single-agent efficacy against drug- resistant Gram-negative bacteria and that is gut-microbiome sparing would have an immediate impact on patients stricken with such infections.